Research Education Core

PROGRAM SUMMARY: RESEARCH EDUCATION CORE
(This Core is identical for all three Partnering Institutions)
The Partnership between Morehouse School of Medicine (MSM)/Tuskegee University (TU)/University of
Alabama at Birmingham O’Neal Comprehensive Cancer Center (MSM/TU/UAB OCCC) presents a distinctive
opportunity to build on our successful accomplishments in education of future cancer research scientists moving
through our pipeline, with an emphasis on underrepresented racial/ethnic minorities. In this U54 renewal
application, we propose a seamless integration of our cancer education programs by focusing on “hard”
(structured courses/training developed through previous U54 funding) and “soft” skills (e.g., career
development roadmap, interviewing skills) needed to facilitate movement through our pipeline into the cancer
research continuum, with the goal of having a diverse workforce in cancer research. This will be accomplished
through the following specific aims: Aim 1. To develop and implement integrated cancer research education
programs to link high school, undergraduate, and graduate/medical students with postdoctoral fellows, medical
residents, and Early Stage Investigators (ESIs), and senior-level researchers/mentors with a particular focus on
underrepresented racial/ethnic minorities in science. Four integrated programs will be utilized: (a) the Granting
Research Opportunities in Wellness by Creating Exciting Learning Laboratories in Science (GROW CELLS)
for high school students; (b) the Cancer Research Immersion Student Program (CRISP) for undergraduate
students; (c) the Summer Cancer Research Education Program (SCREP) for graduate and medical students;
and (d) the Health Disparities Research Education Program (HDREP) for medical residents, postdoctoral
fellows, and ESIs. Aim 2. To link all levels of cancer research scholars with the Outreach Core to share their
research findings with community members, obtain community feedback on relevant topics for future research
(e.g., Cancer Info Cafés), and develop publications and communications for lay audiences (e.g., blogs or posts
on social media, YouTube videos, policy briefs). Aim 3. To implement a mixed-method, triangulated evaluation
of the proposed research education activities across the pipeline. These efforts will increase the recruitment and
retention of underrepresented minorities in science, specifically in cancer research, that are congruent with the
goals expressed in the NIH’s Interest in Diversity Statement.